Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
Cornell’s Roybal Center–The Translational Research Institute on Pain in Later Life (TRIPLL) has developed
innovative approaches and an effective infrastructure for the translation of behavioral and social science
research to improve the health and well-being of older adults. TRIPLL maximizes the joint resources for aging-
related research at Cornell University, uniting social and behavioral scientists and experts in translational
research at Cornell’s Ithaca campus with researchers at Weill Cornell Medicine and Cornell Tech in NYC.
TRIPLL’s Administrative Core (AC) will build on the structure we successfully implemented over the past five
years to include working actively to foster multidisciplinary collaborations across NIH-funded Centers and
engage and supporting researchers across different career stages and along the NIH Stage Model continuum.
The AC’s flexible organization will allow TRIPLL to identify, respond to, and take advantage of new trends and
developments in the field, such as advances in research design (e.g., adaptive clinical trials), as well as
implementation and evaluation science methodologies. The AC will build on NIA’s investment over the past 5
years by expanding support to develop scalable behavioral interventions that target older adults with a focus
on under-represented populations adversely affected by pain. Given the continued high prevalence and burden
of pain in older people, and the movement away from primary reliance on surgical and pharmacological
interventions to treat pain, it is crucially important to develop, test, and disseminate treatment alternatives.
The AC will provide the overall strategic vision for the Center, conduct national competitions to identify
innovative clinical trials to support, foster an environment that promotes opportunities for external
collaborations with respect to behavioral intervention development activities, conduct evaluations of Center-
related activities, and serve as a national resource for the behavioral and social intervention research
community. TRIPLL AC aims are to: 1) Conduct the management tasks of the Center; 2) Launch national
competitions to fund clinical trials in Years 2-5; 3) Convene advisory committees, including an external
advisory committee, internal advisory committee and industry advisory board to help to shape the projects
TRIPLL supports and help to identify sources of project co-funding; 4) Expand TRIPLL’s reach by
strengthening existing and establishing new strategic collaborations; 5) Conduct formal evaluations of Center-
related activities; and finally 6) Oversee all dissemination activities. The AC will devote resources to maintain a
vigorous, comprehensive program of dissemination of new research findings and targeted outreach to
constituencies and consumers who would benefit from TRIPLL-developed programs. Accomplishment of these
aims will help us to maintain/expand a vibrant Center, composed of investigators skilled in conducting
translational research and one that generates principle-driven behavioral interventions designed to mitigate
pain and enhance quality of life for large numbers of older adults adversely affected by pain.